Development of a Tunable Protein Release Hydrogel for the Enhancement of CAR T cell Activity

Project Summary and Abstract
Chimeric antigen receptor (CAR) T cells are genetically engineered T lymphocytes designed to sense
antigens and mount an immune response. Though CAR T cells have received FDA approval for the treatment
of several hematologic malignancies, success in solid tumors is limited by the immunosuppressive tumor
microenvironment, and treatment-limiting adverse effects such as on-target, off-tumor toxicity and cytokine
release syndrome. Though investigators report strategies for mitigating these limitations such as biomaterials for
reshaping the tumor microenvironment, and logic-gated CAR T cells to prevent non-specific toxicity, no proposed
strategy has overcome each of these barriers. To surmount these limitations, I propose the use of a novel self-
assembled hydrogel for implantation into tumor. This hydrogel will be used in conjunction with a split CAR T cell
called a zipCAR, which uses a split adaptor protein (zipFv) to sense antigens. The hydrogel is composed of a 4
arm PEG linker decorated with leucine zippers that can be loaded with zipCargo proteins (payload proteins that
are modified with a leucine zipper, including zipFv). The hydrogel supplies the zipFv adaptor protein, cytokines
(IL-7), and chemokines (CXCL9). I hypothesize that the use of this in situ hydrogel will overcome the
barriers to CAR T cell therapy in solid tumors by: 1) opposing T cell anergy and promoting proliferation
in the resection cavity; 2) preventing antigen escape via encapsulation of zipFvs targeting multiple
antigens; and, 3) imparting spatiotemporal control over CAR T cell activity. Aim 1 will demonstrate the
advantage of the hydrogel by monitoring CAR T cell migration and proliferation in a murine model of ROR1+
lung cancer. Aim 2 will document the efficacy and safety advantages of the hydrogels in a toxicity model of lung
cancer. To demonstrate prevention of antigen escape, ROR1- and MSLN-deficient lung cancer cell lines will be
created using CRISPR-Cas9 knockouts. In a murine model of antigen escape, these cells will be used to
demonstrate superior efficacy in mice treated with zipCAR T cells and hydrogels loaded with zipFvs against both
antigens.
This proposal builds around five key components of critical research and clinical skills to support my
development into an independent engineer/scientist: (1) an interdisciplinary research project focusing on
novel surgical biomaterials for enhancement of CAR T cell activity; (2) multi-disciplinary mentoring from Drs.
Grinstaff (biomaterials), Wong (immunotherapy); and, Colson (clinical medicine, animal models, and
immunology), (3) academic engineer-scientist in research conduct and communication skills, (4) clinical
awareness program, overseen by Dr. Yolonda Colson a nationally recognized surgeon, and (5) professional
development activities to guide my training goals.

Public health relevance
Project Narrative This proposal describes the training and mentoring of Ms. Sarah Adams and her research project to treat solid tumors using a novel biomaterial in conjunction with a split and programmable chimeric antigen receptor (CAR) T cell system. Using this system, she describes a method for overcoming barriers to efficacy of CAR T cells in solid tumors, specifically poor T cell persistence in the tumor microenvironment, lack of specific antigens, and treatment-limiting adverse effects. The capability of this novel therapeutic system to promote CAR T cell proliferation, prevent antigen escape, and mitigate adverse events will be evaluated.